Health and Well-being Effects on Later-life Divorce and Subsequent Repartnering

Health and Well-being Effects on Later-life Divorce and Subsequent Repartnering
R15 Renewal Application Abstract
Susan L. Brown and I-Fen Lin, MPIs
The gray divorce rate, which is the rate of divorce among those aged 50 and older, doubled between 1990 and
2010, rising from 5 to 10 divorcing persons per 1,000 married persons. As of 2019, it persists at this high level.
More than 1 in 3 people who divorced in 2019 were ages 50+ compared with less than 1 in 10 in 1990. Older
adults are at risk for poor health after gray divorce. Depressive symptoms increase following divorce and
remain elevated for four years, a protracted recuperation process that belies the two prevailing models of
divorce adjustment. For older adults, adjustment does not occur after a brief crisis period, nor is it elusive
because divorce is an enduring, chronic strain. Rather, gray divorce is followed by a slow but eventual
recovery, which we term the convalescence model. The adjustment processes following gray divorce appear to
be distinctive but remain poorly understood, underscoring the urgency of examining population heterogeneity
in post-divorce adjustment among older adults. Guided by the stress process perspective, our central
hypothesis is that women’s and men’s personal and social resources shape their divorce adjustment
experience, determining whether they hew to the crisis period, convalescence, or chronic strain model. We use
prospective, longitudinal data from the 1998-2020 Health and Retirement Study to address three aims. First,
we investigate the patterns of post-divorce adjustment and how personal and social resources are associated
with various adjustment trajectories. Second, we examine the linkages between post-divorce adjustment
trajectories and repartnering. Third, we establish adjustment trajectories following repartnering and examine
how post-divorce adjustment shapes post-repartnering health and well-being. The focus of this renewal
application aligns with NIA’s strategic plan because it addresses the effects of interpersonal factors on aging,
including the mechanisms through which these factors exert their effects, and informs ways to improve the
health and well-being of adults as they age. This project fully incorporates two undergraduate and one
graduate research assistant to expose students to all stages of the research process and enhance the BGSU
research environment.

Public health relevance
Narrative Gray divorce (divorce after age 50) is an emerging public health issue that is driving an increase in unmarried older adults, who are at risk of poor health. Adjustment to gray divorce often involves a protracted recuperation process, although presumably some individuals recover more quickly whereas still others experience ongoing, chronic strain. It is essential to investigate population heterogeneity in the adjustment patterns of older adults following gray divorce as well as the potential ameliorative effects of repartnering for women and men.